Gene Discovery

Gene Discovery - Immunotherapy has been most successful when targeted to differentiation antigens expressed on hematopoietic tumors and melanomas in large part because the target antigens are not expressed on essential cells or organs. Other cancers in which this approach could be successful are prostate, breast and ovary. To identify target antigens in prostate and breast cancers we have developed a computer based method to search the EST data base for ESTs that are expressed in prostate or breast cancer and not in other essential organs or cells. We have validated this approach experimentally and used it to identify several genes/proteins expressed in prostate cancer and not in essential normal organs. These include TARP, PAGE4, GDEP and PATE. TARP is a nuclear protein that controls growth of prostate cancer cells. It is also expressed in breast cancer. PAGE4 is a cytoplasmic protein. GDEP is a small nuclear protein and PATE is a secreted protein with properties suggesting it may be a growth factor. We have also discovered two new members of the MRP family, one of which (MRP9) is highly expressed in breast cancer.